The Effects of Stanford Accelerated Intelligent Neuromodulation Therapy on Explicit and Implicit Suicidal Cognition

ABSTRACT
The overarching aim of this proposal is to test the efficacy and safety of a highly efficient and personalized
repetitive transcranial magnetic stimulation (rTMS) method, termed Stanford Accelerated Intelligent
Neuromodulation Therapy (SAINT). In this proposal, we will utilize SAINT as a rapid-acting intervention for the
reduction of explicit and implicit suicidal cognition within the context of an emergency psychiatric admission for
suicidal thoughts and behaviors. Although rTMS is FDA approved for treatment-resistant depression (TRD),
the average required treatment application is 6 weeks before signs of symptomatic improvement, which is not
an optimal strategy for symptomatic treatment of an acute suicidal crisis. This application is motivated by three
recent findings in the neuromodulation field. First is a sham-controlled pilot study evaluating an accelerated
conventional rTMS protocol, where multiple stimulation sessions were safely delivered to the left dorsolateral
prefrontal cortex (L-DLPFC) across three days in patients with suicidal ideation. This study demonstrated that
conventional rTMS can be ‘accelerated’ as well as demonstrated a signal of reductions in explicit suicidal
cognition. Second, there are two notable randomized trials of intermittent theta-burst stimulation applied to the
L-DLPFC that demonstrated the efficacy of intermittent theta burst stimulation (iTBS) as a treatment for TRD, a
condition commonly associated with suicidal cognition. iTBS has been demonstrated to have 5X the pulse
potency of conventional rTMS, which allows for a much-reduced stimulation session time in comparison to
traditional rTMS and therefore makes multiple treatments per day a feasible intervention. The final innovation is
that rTMS targeting utilizing resting state functional connectivity improves antidepressant outcomes of rTMS.
We designed an approach, which we termed SAINT, which utilizes numerous applications of iTBS per day, as
per principles of spaced learning theory (optimized intersession-intervals), within a functional connectivity
derived target (L-DLPFC-sgACC). In TRD, we have observed dramatic changes in mood and associated
explicit suicidal cognition using SAINT. We propose utilizing SAINT to modulate the neural circuitry that
underlies explicit and implicit suicidal cognition along with moderators/mediators (hopelessness, anhedonia,
and depression). We will conduct a randomized, controlled trial of SAINT applied to the L-DLPFC-sgACC to
assess efficacy of the approach in reducing suicidal cognition in hospitalized psychiatric inpatients.

Public health relevance
PROJECT NARRATIVE We recently developed a form of neuromodulation termed SAINT that induces remission in 90% of individuals with treatment-resistant depression. SAINT-induced remission is associated with significant reductions in explicit suicidal cognition. This project aims to elucidate the nature of the suicidal cognition changes produced by applying SAINT to the DLPFC-sgACC of acutely suicidal inpatients.